Carver College of Medicine Clinical Neuroscientist Training Program (CNS-TP)

PROJECT SUMMARY
Brain diseases such as Alzheimer's disease, glioma, Parkinson's disease, epilepsy, stroke and amyotrophic
lateral sclerosis devastate the lives of millions of patients and their families. Despite decades of research
costing billions of dollars, these and other brain diseases still lack accurate diagnostic tools, effective disease-
modifying therapies, adequate symptomatic managements, or even well-defined mechanistic causes. These
failures stand out particularly in light of incredible advances in basic scientific knowledge. Thus, there is a
critical need for clinicians to be involved in basic research on human brain disease since they are well suited to
identify new approaches. The University of Iowa Clinical Neuroscientist Training Program (CNS-TP) is
designed as an efficient pathway to train outstanding neurology, neurosurgery and neuropathology residents in
basic research, with the goal of increasing the percentage of trainees who continue in a long career as
productive clinician-scientists.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Physician scientists bring unique skills to scientific investigation and offer enhanced opportunities to translate basic scientific discovery to diagnosis and treatment of human disease. This program seeks to meet the need for more neurologists, neurosurgeons and pathologists trained in basic neuroscience.